The Impact of Perinatal Fentanyl on Dopamine Neuron Circuitry and Behavior

Project Summary
Use of illicit substances has reached endemic levels in the United States with over 91,000 deaths due to drug
overdose occurring in 2020. This has largely affected women of childbearing age as opioid use disorder has
more than quadrupled among pregnant women in the past 20 years. Both clinical and preclinical studies show
that opioid exposure during gestation can lead to developmental delays, cognitive impairment, anhedonia and
reduced motivation in offspring. Opioids induce neuroadaptations in the mesolimbic dopamine pathway, which
is largely implicated in reward. The pathway originates in the ventral tegmental area (VTA) where dopamine
neurons project to the nucleus accumbens (NAc). Prolonged opioid use has been shown to reduce the soma
size of VTA dopamine neurons and decrease dopamine output in the NAc. In addition, a recent study in our lab
found downregulation of important genes for VTA dopamine neuron maturation and axonal guidance in the VTA
of juvenile mice perinatally exposed to fentanyl (PFE), a highly potent opioid, compared to controls. Preliminary
data from our lab indicates that PFE mice exhibit reduced soma size, motivation as indicated by active lever
pressing in an operant task and cue evoked dopamine signaling compared to controls. Thus, I hypothesize that
perinatal fentanyl exposure will lead to reduced soma size in VTA dopamine neurons and their proper axonal
targeting, along with decreased dopamine release and motivation in adulthood. First, I will use differential gene
expression and morphological analysis across multiple developmental timepoints to understand the
transcriptional and circuit level impact of perinatal fentanyl exposure on the developing mesolimbic dopamine
pathway. Second, I will use fiber photometric recording of dopamine during an operant behavioral task to
investigate how perinatal fentanyl exposure affects dopamine signaling in the NAc and motivation in adulthood.
Through these experiments, I aim to uncover the impact of perinatal fentanyl exposure on the development of
the mesolimbic dopamine pathway and its function in adulthood.

Public health relevance
Project Narrative In the past 20 years, the incidence of newborns born with neonatal abstinence syndrome as a result of their mothers using opioids throughout pregnancy has quadrupled, resulting in an associated $1.5 billion in related annual hospital charges. Infants born with in utero opioid exposure often exhibit developmental delays, and behavior and learning problems, however, the long-term effects of in utero exposure to opioids, including the highly potent opioid fentanyl, remain unknown. This proposal will elucidate the impact of perinatal fentanyl exposure on neuronal and circuit development.